Core D: Biospecimen and Pathology Core

PROJECT SUMMARY/ ABSTRACT
The purpose of this Biospecimen and Pathology Core is to provide tissue, cells and pathology services to the
three research projects and career enhancement, or research development awardees covered by this
application. To achieve these goals, the Lymphoma SPORE combines pathology resources from the Dan L
Duncan Comprehensive Cancer Center (DLDCCC) at Baylor College of Medicine (BCM) and its affiliated
institutions with those of Houston Methodist Hospital to ensure adequate numbers and timely delivery of
tissue/blood samples for the projected needs of SPORE and external investigators. The proposed core
resource will therefore co-ordinate acquisition of tissue for banking from lymphoma and CLL patients at
affiliated hospitals in the Texas Medical Center, by relying on established tissue collection and distribution
systems. The capacity to obtain samples from multiple affiliated hospitals will greatly increase the number of
specimens we are able to analyze, store and distribute from our diverse catchment area. The core also
provides pathology services including routine tissue preparation, immunohistochemical staining, laser capture
microdissection, preparation of tissue microarrays, flow cytometry, detection of minimal residual disease and
in situ hybridization for viral RNAs. These tasks are essential to the successful completion of planned
experiments in each project and will be performed by expert pathologists and histotechnologists with
substantial experience in providing core services to SPORE investigators. This core is also responsible for
coordinating supply of tissue to the Patient-Derived Xenograft and Advanced In Vivo Models Core of the
DLDCCC, resources that will be of particular use to our investigators. This core also accesses a cancer
genetics laboratory for specialized molecular studies including FISH and sequencing and bioinformatics
support to support tissue-banking software needs for the lymphoma SPORE. Bioinformatics support comes
from the DLDCCC Biomedical Informatics Group that supports OpenSpecimen, a secure web-based modular
application that serves as the unifying hub for all DLDCCC-based biorepositories, including the BCM Breast
and Lymphoma SPOREs. In the last funding period, the Resource Allocation Committee approved 25
requests from SPORE and external investigators for tissue or blood samples.

Public health relevance
NARRATIVE The goal of the Biospecimen and Pathology Core is to provide high quality tissue and blood samples from lymphoma patients to investigators undertaking translational research studies in lymphoma. The core pathologists also provide support to the clinical trials in this SPORE by reviewing tissue and performing staining and other molecular tests for target antigens.